The Role of Leptin in Inflammation-Driven Bone Loss

PROJECT SUMMARY
Leptin, originally identified as a regulator of energy metabolism, is required for normal bone growth and
turnover, making the adipokine an attractive candidate for coupling optimal bone accrual and turnover
balance to energy availability. However, not all skeletal actions of leptin are beneficial; there is compelling
evidence that leptin contributes to aging-related skeletal pathologies by promoting a proinflammatory cascade
mediating inflammation-driven bone loss. The molecular mechanisms mediating the skeletal actions are
poorly defined. We have strong preliminary data indicating that leptin influences bone metabolism, both
beneficially and detrimentally, by activating leptin receptor (OB-R) on cells (predominately immune cells)
derived from hematopoietic stem cells (HSCs). Based on this, we hypothesize that: (1) leptin signaling by
immune cells is necessary for normal bone growth, maturation and turnover, but (2) in the presence of
chronic inflammation, leptin signaling by immune cells promotes net bone loss. The proposed research will
test these hypotheses in male and female mice by accomplishing two Specific Aims. Specific Aim 1:
Determine the contribution of leptin signaling by immune cells to bone accrual and turnover balance.
We will reconstitute the immune system of growing and adult male and female mice with HSCs from OB-R+
wild type (WT) or OB-R- db/db mice using adoptive transfer to establish the overall contribution of OB-R on
immune cells to leptin regulation of bone accrual in growing mice and turnover balance in adult mice,
respectively. We will then determine if the skeletal actions of leptin are primarily mediated via OB-R on cells
in the osteoclast lineage by adoptively transferring OB-R+ and OB-R- monocytes into mice with reduced
ability to form osteoclasts (Ccr2- mice). Specific Aim 2: Determine the contribution of leptin signaling by
immune cells to inflammation-driven bone loss. We will reconstitute the immune system of growing and
adult male and female mice with HSCs from OB-R+ or OB-R- mice as in Specific Aim 1 and induce local
inflammation by placing polyethylene particles over calvaria to model aseptic periprosthetic bone loss. These
studies will establish the overall contribution of OB-R on immune cells to inflammation-driven bone loss. The
contribution of OB-R on immune cell subsets to normal bone turnover balance and particle-induced osteolysis
in adult mice will then be evaluated following engraftment of subsets of OB-R+ and OB-R- immune cells into
mice unable to generate/recruit monocytes (Ccr2-), T-cells (Tcra KO), B-cells (muMT-), or mast cells (KitW-sh).
Successful completion of this research will have a major impact on the field by expanding existing concepts
regarding the role of leptin in skeletal health and disease. Our approach will provide a powerful tool for
unraveling mechanisms mediating the complex actions of leptin on the skeleton and immune systems. The
proposed research has the potential to provide new insights for the development of interventions to interrupt
leptin-mediated inflammatory cascades without compromising the beneficial skeletal actions of the adipokine.

Public health relevance
PROJECT NARRATIVE Leptin is a hormone that acts on multiple organs, including the immune system and bone. The proposed research tests the hypothesis that leptin, acting on subsets of immune cells, is a key positive contributing factor to normal bone accrual and turnover balance, but also enhances bone loss caused by chronic inflammation. This knowledge is important because failure to accrue sufficient bone mass and bone loss due to chronic inflammation contribute to bone fractures in the elderly.